Defining a Health Insurance Package for the Uninsured

This protocol is designed to determine how uninsured patients would choose to define their health insurance benefit package. Thus far the study instrument has been designed and has been pilot tested. The study design has been completed. Patient recruitment is scheduled to begin in July 1999.